Development of antibodies for the detection of conformational changes in PSD-95 that regulate synaptic plasticity

Abstract
Local protein phosphorylation is essential for synaptic plasticity, with proline-directed kinases such
as GSK3β and CDK5 playing key roles in regulating synaptic modifications critical to long-term
memory formation. Notably, phosphorylation of postsynaptic density protein 95 (PSD-95) by
GSK3β is rapidly induced upon NMDAR-dependent long-term depression (NMDAR-LTD),
destabilizing PSD-95 from the synapse and promoting its exit from postsynaptic spines. Proline-
directed phosphorylation—a unique form of protein phosphorylation—can induce conformational
changes in protein targets via cis-trans isomerization of the prolines following phosphorylated
residues. Although the impact of this regulatory mechanism is well-characterized in cancer, its
function in synaptic plasticity is largely unexplored. In this project, we aim to develop conformation-
specific antibodies to detect cis and trans isomers of phospho-T19 in PSD-95, addressing a
fundamental gap in our understanding of excitatory synapse biology. Specifically, we will
investigate whether phosphorylation at serine/threonine-proline bonds in PSD-95 drives
conformational changes that affect its biological function in synaptic plasticity. Our recent findings
suggest that phosphorylation at T19 significantly alters the conformation of PSD-95’s N-terminus,
affecting synaptic stability. The conformation-specific antibodies to be generated in this study will
provide novel tools to directly monitor cis-trans isomerization states of PSD-95, enabling us to
assess their role in synaptic stability and excitatory synaptic function in future studies. These
experiments will offer unprecedented insights into the role of proline-directed phosphorylation and
cis-trans isomerization in synaptic plasticity, advancing our broader understanding of regulatory
mechanisms in excitatory synapses.

Public health relevance
PROJECT NARRATIVE Around 1 in 7 of the world population suffers from some type of mental health disorder and these numbers are likely an underestimation. Most of these conditions arise from dysfunction at the excitatory synapse. The proposed studies aim to develop tools to help us understand key regulatory mechanisms responsible for proper excitatory synaptic function. We hope these studies will one day lead to the development of better treatment options for patients suffering from these debilitating diseases.